Identification of a Site Critical to the Avpr1b's Effects on Behavior

DESCRIPTION (provided by applicant): The vasopressin 1b receptor has been consistently implicated as a key factor in the regulation of social behavior;however, the precise region of the brain where the vasopressin 1b receptor is acting has not been identified. The objective in this application is to identify neural substrates on which vasopressin acts via the vasopressin 1b receptor to affect social behavior in an experimental animal model. Specifically, the proposed experiments have been designed to test the central hypothesis that vasopressin 1b receptor mediated-signaling, specifically within the CA2 region of the hippocampus, contributes to normal displays of social behavior. The rationale for these studies is that identification of the neuroanatomical substrate upon which vasopressin acts via the vasopressin 1b receptor to impact social behavior will potentially further our understanding of aberrant social behavior. This knowledge is relevant to the NIH's mission in that it will potentially provide new targets for psychiatric disease treatment in humans. The specific aim of this proposal is to determine the contribution of the vasopressin 1b receptor within the CA2 region of the hippocampus to social behavior. This will be achieved by coupling experimental animal behavioral studies with targeted, site-specific, gene knockdown to identify pathways important to the regulation of behavior. It is expected that completion of this research will lead to the identification of one of the important neural substrates contributing to the vasopressin 1b receptor's regulation of social behavior. The proposed research is significant because the findings of this work will serve as a foundation for a more focused examination of the interaction between vasopressin and other neurotransmitter systems;ultimately resulting in a more complete understanding of the regulation of social behavior. PUBLIC HEALTH RELEVANCE The proposed studies are important because they have the potential to identify one of the key neural substrates that likely contributes to manifestations of aberrant social behavior. The proposed research has relevance to public health, because the neurochemicals, neurosubstrates, and circuits that underlying the regulation of behavior are evolutionarily conserved. Thus, the findings are ultimately expected to be applicable to the health of human beings.